Rapid ART and HIV Care Engagement Among Young Black and Latinx Sexual and Gender Minorities with HIV: A Mixed Methods Study

PROJECT SUMMARY
Parent Grant: Young people living with HIV (LWH) in the developmental periods ages 16-28 years, which we
refer to as “youth and emerging adults” (YEA), have the lowest rates of engagement along the HIV care
continuum (HCC), most pronounced for African American/Black and Latinx YEA-LWH. Yet, our knowledge of
factors that promote or impede engagement along the HCC is insufficient. The mixed methods prospective
longitudinal study focuses on African American/Black and Latinx (AABL) YEA-LWH (ages 16-28 years with HIV
in NYC and Newark, NJ, N=270) both with and without viral suppression and uses quantitative, qualitative,
biomarker (HIV viral load, drug use), and ecological momentary assessment approaches to uncover, describe,
and better understand factors contributing to trajectories of engagement along the HCC over time, with
precision, including from YEA-LWH’s perspectives. Proposed Supplement: Rapid ART has become standard
policy in HIV treatment on the international, national, and local levels over the last few years. As HIV clinical
care sites move to rapid ART implementation, it is important to understand the contextual factors that influence
decision making and behavior at this critical juncture along the HCC. While the literature mainly explores the
perspectives and experiences of people newly diagnosed adults with HIV, there is a dearth of understanding
around YEA-LWH who have been out of care and/or decide to re-engage in care and reinitiate rapid ART. In
addition, the U.S. HIV epidemic is characterized by persistent disparities for younger people as well as
racial/ethnic, gender, and sexual minorities. It is vital to illuminate the barriers, facilitators, and important
contextual factors that influence decisions and behaviors regarding ART re-initiation for AABL sexual and/or
gender minority (SGM) YEA-LWH. These critical questions have not yet been explored in the literature. This
mixed methods supplement proposal will involve a quantitative analysis of the R01 parent study data
examining associations between rapid ART initiation at diagnosis (which is not an aspect of the parent study),
demographic and psychosocial factors (substance use, mental health, HIV-related stigma, intersectional
stigma, medical distrust, and discrimination), and HIV care engagement. We hypothesize that rapid ART will be
associated with HIV care disengagement. For the qualitative portion, we will sample a group of 30 participants
recruited from the parent study, half recently re-engaged in care/re-initiating ART and half disengaged/not on
ART, to participate in in-depth interviews, Photovoice methodology and focus group discussions to explore the
aforementioned psychosocial factors and elicit and describe other emergent contextual factors, driven by a
multi-level approach grounded in social action theory. The results from this supplement will contribute to
equity-focused recommendations for policy-makers and providers to support AABL SGM YEA-LWH in HIV
care re-engagement and rapid ART initiation.

Public health relevance
PROJECT NARRATIVE African American/Black and/or Latinx youth and emerging adults living with HIV, who are mostly sexual and gender minorities, experience the highest rates of HIV care disengagement and poor outcomes along the HIV care continuum. Given rapid antiretroviral therapy (ART) – the initiation of ART immediately after diagnosis or upon return to care – is a potential strategy to address gaps in the HIV care continuum in this population, we aim in this study to examine associations between rapid ART, psychosocial factors (e.g. stigma, discrimination, mistrust, mental health and substance use), and HIV care engagement, as well as understand the multilevel barriers and facilitators to HIV care re-engagement and ART re-initiation. We hypothesize that rapid ART will be associated with lower HIV care engagement, and that the aforementioned psychosocial factors will mediate or moderate the association.